Transitions to Adulthood and Health Risk Among U.S. Young Adults

Project Summary Health risks such as smoking, physical inactivity, heavy alcohol consumption, obesity, high blood pressure, and inflammation are important determinants of premature mortality among U.S. adults. Further, these risks are socially patterned. Research has shown that educational attainment, marital status, fertility patterns, and employment status are all associated with adult health behaviors and outcomes (Cutler & Lleras-Muney 2010; Pampel et al. 2010; Umberson et al. 2010; Waite & Gallagher 2002). Yet, we know relatively little about how the aforementioned health risks are patterned by combinations of these social statuses, even though they are interdependent. For example, entering the workforce is often a competing alternative to further education, or individuals may delay parenthood until after marriage. This project focuses on how the transition to adulthood, defined as the sequencing and combination of different markers of adulthood, influences the health risks of young adults. The overall objective of this research project is to understand the development of differential health risks of young adults aged 26 to 32 in the United States. The specific aims of the project are to: (1) distinguish unique transition to adulthood profiles of U.S. young adults through examination of the timing, sequence, and grouping of adulthood markers; (2) identify health risk profiles among U.S. young adults through determining how health behaviors and outcomes are patterned across individuals; (3) identify relationships between transition profiles and health risk, and (4) estimate the moderating effects of race/ethnicity, nativity, sex, and class background on the transition-health risk relationships. To accomplish these aims, the project will use data from the National Longitudinal Study of Adolescent to Adult Health (Add Health). Add Health is uniquely suited for this project because it: (1) is recent, (2) is longitudinal, (3) spans the transition to adulthood, (4) offers detail on health risks including biomarkers, (5) provides geographic information, and (6) offers genome-wide association study (GWAS) data. This project will use the most appropriate and contemporary quantitative methods to accomplish the aims. The results will provide a more comprehensive description of health risk patterns of U.S. young adults. The project will move forward our understanding of how combinations of individual, family, and social factors influence the health risks of young adults in the United States, an especially important topic in the context of today's widening health disparities and changing health risks. The fellowship period includes a number of activities to support the proposed research and prepare the applicant for a productive career conducting interdisciplinary research that integrates biological and social approaches to health. The two years will include coursework, formal and informal mentoring, training in specific methodological and theoretical approaches, and support in professionalization, the ethical conduct of research, and networking.

Public health relevance
PROJECT NARRATIVE The overall objective is to understand the development of differential health risks of young adults aged 26 to 32 in the United States. This project is the first to link different patterns of the transition to adulthood, defined as the sequencing and combination of different markers of adulthood, to the health risks of young adults. The results will produce a comprehensive description of population health risk among U.S. young adults, sources of differential health risk in young adulthood upon which interventions can be effective, and pathways that illustrate health disparities across race/ethnicity, gender, immigrant status, and class background.